Uncovering the Roles of PIP5KDuring Cell Migration

Cardiovascular diseases and pulmonary fibrosis remain leading global health challenges, with
cardiovascular diseases accounting for 17.9 million deaths annually and pulmonary fibrosis carrying a median
survival time of only 3 to 5 years post-diagnosis. Despite current treatment options, patients with pulmonary
fibrosis continue to experience high mortality rates. A major challenge to developing targeted treatments is the
limited understanding of the molecular and biophysical mechanisms driving these diseases, specifically, how a
cell initiates membrane asymmetry, establishes polarity, and enables directional migration—the fundamental
biological processes involved in developing and maintaining cardiovascular and pulmonary systems. My recent
findings reveal that phosphatidylinositol 4-phosphate 5-kinase (PIP5K), which synthesizes phosphatidylinositol
4,5-bisphosphate (PI(4,5)P2), undergoes dynamic partitioning and reciprocally inhibits Ras small GTPase
activity during cell migration. Therefore, we target PIP5K and our overall hypothesis is that PIP5K and its effector
Arf GTPase regulate cell migration through differential diffusion-driven dynamic partitioning, modulating Ras
activity and downstream signaling pathways on specific membrane regions. The proposed hypothesis will be
addressed in three specific aims. Aim 1 will determine how dynamic partitioning and binding affinity of PIP5K
contribute to symmetry breaking and polarity establishment in migrating cells. I will measure PIP5K diffusion
coefficients with photo-conversion techniques and single-molecule imaging under varying conditions. I will
investigate how actin and actomyosin networks influence PIP5K partitioning using CRISPR-based gene
disruption and pharmacological inhibitors. These experimental data will be integrated into stochastic simulations
of an excitable network to validate models of symmetry breaking. Aim 2 seeks to identify and characterize the
binding partners of PIP5K to understand its role in regulating Ras activity. I will use TurboID proximity labeling
and Mass Spectrometry to map PIP5K’s interactome, with validation through co-immunoprecipitation and genetic
perturbation. Functional studies will investigate how these partners influence PIP5K and Ras activities during
cell migration. Aim 3 focuses on elucidating the roles of Arf GTPases in regulating cell migration and PIP5K
functions. Using optogenetic tools and CRISPR, I will study how Arf GTPases and their regulators (ArfGEFs and
ArfGAPs) modulate PIP5K localization, Ras signaling, and cytoskeletal dynamics. Biochemical assays will
explore interactions between Arf proteins and PIP5K and their joint regulation of Ras activity. This study will
provide valuable insights into how PIP5K, Arf, and Ras form a signaling cascade to regulate cell migration and
polarity through the Ras/PI3K/Akt pathway and potentially uncover novel therapeutic targets for cardiovascular
and pulmonary diseases. This project aligns with NHLBI’s mission to advance research on heart, lung, and blood
diseases, improving public health through innovative science.

Public health relevance
Project Narrative Cardiovascular diseases and pulmonary fibrosis collectively affect millions of individuals worldwide and remain the leading causes of mortality. This project employs advanced genetic, biophysical, biochemical, and imaging techniques to investigate how PIP5K regulates cell migration and polarity through its interactions with Ras and Arf GTPases. By uncovering these molecular and biophysical mechanisms, this research aims to inform the development of innovative therapies to reduce disease burden and improve health outcomes.